Surveillance and Genomic Characterization of Antimicrobial Resistance in Puerto Rico's Retail Food

ABSTRACT
Antibiotic resistance, a threat to public health worldwide, is exacerbated by misuse and overuse of
antibiotics for therapeutic purposes in human and veterinary medicine. National Antimicrobial Resistance
Monitoring System (NARMS) is a multi-agency federal program that collaborates with public health and
academic institutions in efforts to monitor antimicrobial resistance in bacteria from humans, retail meats,
and food-producing animals. Our aim is to collaborate with the Food and Drug Administration to enhance
the NARMS site in Puerto Rico. Surveillance and Genomic Characterization of Antimicrobial Resistance
in Puerto Rico's Retail Food Program’s primary goal is to enhance, strengthen and sustain antibiotic
resistance surveillance in retail food specimens as part of NARMS. The strategies of this project address
four (4) specific aims: (i) Enhance Routine AMR Surveillance in Retail Meat and Seafood; (ii) Strengthen
Laboratory and Bioinformatics Capacity for AMR Characterization; (iii) Integrate Surveillance with
Response and Workforce Development; (iv) Expand AMR Outreach, Communication, and Stewardship.
Collaborative efforts with the Pennsylvania Department of Health and Penn State University will support
genomic training and data interpretation. Findings will provide critical data to the FDA for regulatory
oversight and inform evidence-based food safety practices across Puerto Rico.

Public health relevance
Project Narrative The Surveillance and Genomic Characterization of Antimicrobial Resistance in Puerto Rico’s Retail Food project will advance fundamental knowledge about the diversity, transmission, and genomic features of antimicrobial-resistant (AMR) bacteria in the food supply. By integrating culture-based methods with whole-genome sequencing and advanced sequencing technologies, this research will improve our understanding of how resistant strains emerge and disseminate across food production and retail environments. The findings will support efforts to reduce illness by informing public health interventions, guiding outbreak response, and strengthening AMR surveillance capacity.